G-RISE: Graduate Research Initiative for Student Advancement at The City College of New York

The rationale for the proposed G-RISE project encompasses dual needs: to improve the quality
and to broaden the demographic reach of advanced biomedical research workforce training in
order to benefit human health care. A group of 34 faculty members at The City College of New
York (CCNY) will leverage a position of research strength in the biomedical sciences, within a
large public university in the heart of an underserved community, to address these needs. This
renewal project will build on the success of our current program to offer coordinated, innovative,
and rigorous Ph.D. training that spans biochemistry, biophysics, bioorganic chemistry,
engineering, and neuroscience disciplines. The proposed program will support cohorts of 15
Ph.D. trainees from underrepresented (UR) groups each year for five years, appointing each
trainee for 2-3 years. The mission of the proposed program is to complement rigorous didactic
and research training with inclusive mentorship and professional skills development for these
Ph.D. trainees, while also benefitting a broader population of STEM trainees and mentors at
CCNY. Our specific objectives and strategies are:
· To recruit and retain talented UR Ph.D. trainees whose biomedical research interests align
with the participating CCNY faculty-led teams. Vigorous recruitment will be coupled with
sound mentee-mentor matching in a supportive and inclusive training environment that
builds research identity bolstered by a strong trainee cohort and a Near-Peer Mentor.
· To graduate Ph.D.’s who have rigorous didactic training that combines disciplinary depth
with interdisciplinary breadth while progressively building independent research design
skills. Interdisciplinary degree tracks and team teaching will be emphasized.
· To graduate Ph.D.’s with research training that fosters individual skills and creativity, team
cooperation, synergy among research groups, and increasingly independent use of state-
of-the-art technology to address important open problems in the biomedical sciences.
· To graduate Ph.D.’s whose training is enriched by co-curricular activities that build skill
sets in communication, ethical and reproducible research, and career exploration.
· To achieve trainee outcomes that include enhanced proportions of UR Ph.D.’s who
achieve timely graduation in biomedical science and engineering disciplines, while also
improving their research productivity and post-Ph.D. placement in the workforce.
In the proposed project, a strategic combination of NIH and institutional resources will allow us to
improve the reach and rigor of biomedical research training at the City College of New York.

Public health relevance
In this renewal application, a group of 34 faculty researchers at The City College of New York (CCNY) proposes to leverage a position of research strength, within a large public university in the heart of an underserved community, to improve the quality and to broaden the demographic reach of advanced biomedical research workforce training that can benefit human health care. Using a strategic combination of NIH and institutional resources, the G-RISE program at CCNY has the demonstrated capacity to support cohorts of 15 Ph.D. trainees from underrepresented groups each year for five years, appointing each trainee for 2-3 years. A coordinated program of stimulating interdisciplinary coursework, rigorous research training, inclusive mentorship, and structured co-curricular activities that build research identity, ethical values, and career readiness are designed to improve the proportion of underrepresented Ph.D.’s who go on to rewarding careers in the biomedical research workforce.